Non-invasive assessment and modulation of brain-gut interoception in humans

PROJECT SUMMARY/ABSTRACT
Interoception refers to the representation of the internal states of an organism, and includes the processes by
which it senses, interprets, integrates, and regulates signals from within itself. Interoception is increasingly
viewed as a bidirectional process between the brain and body, in which multiple feedback and feedforward
loops lead to an internal representation of the body. The vagus nerve is intimately involved in autonomic
control of the upper gastrointestinal (GI) tract, with afferent projections to medullary brainstem nuclei. In turn,
interoceptive pathways can also be directly targeted for clinically beneficial neuromodulation and non-invasive
neuromodulatory techniques that interact with brainstem vagal circuitry, including transcutaneous auricular
vagal nerve stimulation (taVNS), have been reported to modulate efferent visceral vagal pathways via the
engagement of nucleus tractus solitarii (NTS). However, broader understanding of taVNS effects on gastric
function and brain response to gastric interoceptive signaling is needed, and requires tools to directly probe the
gut-brain axis in humans. In our study, we will combine a fully non-invasive experimental framework including
sequential gastric and brain Magnetic Resonance Imaging (MRI) with calibrated meal ingestion and MRI-
compatible taVNS to evaluate the modulation of visceral interoception along the brain-gut axis. Aim 1 will
evaluate gastric function and brain response to gastric interoceptive signaling following calibrated meal
ingestion. In Aim 2, we will then investigate taVNS modulation of gastric function and brain response to gastric
interoceptive signaling. The proposed study will contribute new insights into the bidirectional gut-brain
interaction underlying gastric interoception, and its modulation via non-invasive neuromodulatory techniques
that specifically target interoceptive pathways (i.e. taVNS).

Public health relevance
PROJECT NARRATIVE The primary aims of this single-blind, randomized, sham-controlled cross-over study are to 1) evaluate gastric function and brain response to gastric interoceptive signaling following calibrated meal ingestion in healthy adults; 2) investigate transcutaneous auricular vagus nerve stimulation (taVNS) modulation of gastric function and brain response to gastric interoceptive signaling in healthy adults. Using our fully non-invasive framework including gastric and brain MRI and taVNS, we aim to link the central gastric interoceptive circuitry to objective outcomes of gastric function.